Optic neuropathy in familial dysautonomia: determination of disease mechanisms and functional rescue.

SUMMARY/ABSTRACT
Familial dysautonomia (FD) is a severe neurodegenerative disorder caused by a splice site mutation in intron 20
of the elongator acetyltransferase complex subunit 1 (ELP1). Despite its complex neurological phenotype, FD
patients suffer from progressive blindness that severely affects their quality of life. Patients with FD show a
significant reduction in the thickness of the retinal nerve fiber layer (RNFL) due to progressive and selective loss
of retinal ganglion cells (RGCs). Here, we aim to develop a retina-specific treatment for FD by comprehensive
evaluation of systemic (SMC PTC680) and local (AAV2-U1a-ELP) therapeutic approaches to rescue visual
function in FD. Our previous studies show that genetic or pharmacological modulation of ELP1 splicing or genetic
supplementation of human ELP1 in the retina can rescue RGC loss in FD. However, the efficacy of these
treatment options to rescue visual function in FD has not been investigated. Through a detailed interrogation of
the cellular and visual function of the FD retina, we will not only compare the efficacy of systemic and local
therapeutic approaches to rescue visual function but also better understand the disease pathology. We propose
to evaluate the impact on the visual function of two different therapeutic approaches through comprehensive
visual function testing using electrophysiological and optokinetic methods in novel retina-specific conditional Elp1
knock-out with human ELP1 transgene containing FD mutation (transgenic cKO) mice (Aim 1). To understand
the molecular mechanism of selective RGC loss in FD through the identification of key regulatory pathways
involved in RGC survival which are dysregulated by the reduction of ELP1. We will use single-cell RNA seq
(scRNAseq) to computationally link RGC survival to transcriptomic alterations in the FD mouse RGCs (Aim 2).
Finally, by using patient-derived induced pluripotent stem cell (iPSC) RGCs, we will investigate the RGC
degeneration and test the efficacy of the therapeutic approaches in a human model system (Aim 3). The
proposed work will investigate the efficacy of therapeutic options for FD and uncover the underlying molecular
mechanism behind RGC loss. The proposed work will directly translate to designing the best therapeutic
strategies to treat optic neuropathy in FD.

Public health relevance
PROJECT NARRATIVE We seek to identify the most effective therapeutic approach to rescue visual function in a mouse model of a severe neurodegenerative disease known as Familial Dysautonomia (FD). Moreover, we will use transcriptomics at single-cell resolution to investigate the molecular mechanism behind selective retinal ganglion cell (RGC) loss in FD. The proposed work is highly translational and will be a critical step toward bringing treatment for vision loss in FD patients.